Investigation of factors involved in assembly of the mycolata envelope

PROJECT SUMMARY
Bacteria surround themselves with complex cell structures called cell envelopes to preserve cell integrity, defend
against external threats, and to facilitate uptake and metabolism of nutrients essential for bacterial growth and
survival within the cell’s environment. Bacteria of the order Corynebacteriales possess unique multilayered
envelopes consisting of an arabinogalactan-peptidoglycan cell wall and an outer membrane called the
mycomembrane (MM) composed of lipids called mycolic acids. Mycolic acids are a hallmark feature of these
bacteria and greatly contribute to the pathogenicity of some corynebacterial, nocardial, and mycobacterial
species, such as Corynebacterium diptheriae and Mycobacterium tuberculosis. Much remains to be discovered
about the mechanisms involved in the biogenesis and modification of this unique envelope architecture. In
particular, it is unclear how these organisms coordinate the synthesis of the different envelope layers during
bacterial growth. My preliminary data suggest that TmaT, an enzyme involved in mycolic acid transport to the
mycomembrane is regulated by AftD, an arabinosyltransferase that aids in construction of the arabinogalactan
layer. These data suggest coordinated regulation of the synthesis of the different cell wall layers. Overall, this
work will reveal fundamental mechanisms important for regulation and synthesis of an essential component and
attractive drug target of mycobacterial species. The Specific Aims of this F32 application are:
Aim 1: Elucidate the role of the TmaT-AftD complex in assembly of the mycolata envelope
Aim 2: Characterize new factors required for mycomembrane biogenesis

Public health relevance
PROJECT SUMMARY Bacteria within the Corynebacterineae suborder, such as Mycobacterium tuberculosis and Corynebacterium diphtheriae, pose significant global healthcare challenges, partly due to the distinct cell envelope of these bacteria, which plays a crucial role in their pathogenicity and antibiotic resistance. My research focuses on understanding how the complex mycobacterial cell envelope layers are synthesized to identify new weak points to exploit for antibiotic development.